ITAC NHLBI RECOVER CYBERSECURITY PROGRAM

The RECOVER Cybersecurity Program’s objective is to provide collaborative advisory and operational support services to NIH and RECOVER stakeholders. It will identify data security priorities, assess and manage risks, and adapt current practices for the RECOVER Initiative. The program will support NIH extramural funded awardees to develop, maintain, and apply security practices based on a tailored security framework founded on Federal Information Security Management Act (FISMA) principles